Studies to evaluate the tox and carcinogentic potential of test articles

This Work Assignment type contract, awarded in May, 2005 will involve tasks to evaluate the toxic and carcinogenic potential of various test articles. Work Assignments issued to date include: 90-day and 2-year studies of tetrabromobisphenol A and tetrabromobisphenol A-bis(2,3-dibromopropyl ether);the 90-day studies are completed and study reports are due in winter 2006. 90-day and 2-year studies of green tea extract;the 90-day study is completed and study reports are due in the winter 2006. 90-day and 2-year studies of 5-amino-o-cresol;the 90-day study is completed and reports are due early 2007. 14-day, 90-day and 2-year studies of resveratrol;prestart activities are underway and the 14-day study is scheduled to start in the fall 2006. 2-year study of bromodichloroacetic acid;the study is schduled to start in the fall 2006. 2-year study of indole-3-carbinol;the work assignment is under negotiation and should start in the fall 2006. Keywords Carcinogenicity;toxicity;bioassay;F344 rats;B6C3F1 mice;tetrabromobisphenol A;tetrabromobisphenol A-bis(2,3-dibromopropyl ether);green tea extract;5-amino-o-cresol;resveratrol;bromodichloroacetic acid;indole-3-carbinol.